Design of a B cell tetramer to track PfMSP2-specific B cells

Project Summary
The protozoan parasite Plasmodium is the causative agent of malaria, which remains one of the most
prominent public health challenges in the world today. Antibodies play a primary role in protection from severe
disease caused by blood-stage infection. However, repeated infections over an extended period are required
to induce protective humoral immunity. It is unclear if protective antibodies are derived from short-lived
plasmablasts through an extrafollicular response or long-lived plasma cells via the germinal center. Induction of
the latter is the primary goal of effective vaccines. While Plasmodium-specific antibodies are detectable in the
serum of individuals with clinical malaria, the cell biology underlying these antibody responses remains
unknown. Here we propose developing a Plasmodium-specific B cell tetramer to track antigen-specific B cell
responses to close gaps in our understanding of the humoral response to Plasmodium. Using the blood-stage
antigen, merozoite surface protein 2 (MSP2), a candidate antigen for a blood-stage malaria vaccine, we will
generate two B cell tetramers, one containing a full-length recombinant P. falciparum MSP2 protein and
another encompassing a chimeric PfMSP2/8 protein. The former can form fibrils in vitro, while the latter does
not. Hence, we predict the chimeric protein will offer such benefits as increased stability over time and the
identification of a greater number of MSP2-specific B cells that bind a broader number of epitopes across
PfMSP2 than a tetramer composed solely of rPfMSP2. In sub-aim 1, we will monitor MSP2 fibril formation and
determine each B cell tetramer's ability to recognize antigen-specific B cells ex vivo after immunization of mice
with either rPfMSP2 or rPfMSP2/8. Then in sub-aim 2, we will confirm the specificity of the B cells for binding
MSP2 by ELISA through the generation of monoclonal antibodies based on the B-cell receptor sequences of
tetramer positive B cells. Confirmation of the B cell tetramers' binding specificity is essential before using them
to identify MSP2-specific B cells in the blood of individuals from malaria endemic areas or individuals
participating in vaccine studies.

Public health relevance
Project Narrative Public Health Relevance: Malaria is a disease caused by protozoan parasites of the genus Plasmodium, which is transmitted by mosquitos. Despite ongoing eradication campaigns and the availability of anti-malarial drugs, inroads to eliminate and eradicate this disease have hit hurdles recently, as clinical cases of malaria and malaria-related deaths are leveling off rather than declining in most regions, while in others, the numbers are on the rise. Thus, there is an emphasis on understanding how the immune response, cell- and antibody-mediated, provides protection against this infection to determine how protective immunity can be enhanced in a vaccine setting to offer and maintain immunity against this disease.